Administrative Core

Administrative Core Summary
The OK-INBRE Administrative Core provides career development opportunities for faculty, students, and
trainees and provides the logistical support for the overall OK-INBRE network. The Administrative Core also
includes the evaluation component of the network. Oversight, assessment, and evaluation of all OK-INBRE
program activities are provided by the External Advisory Committee (EAC), the Executive Committee, known as
the OK-INBRE Deans’ Council (DC) comprised of a representative from each OK-INBRE network institution, and
the Steering Committee (SC) comprised of the Presidents of each institution in the OK-INBRE network. The
primary roles of the EAC will be to oversee the scientific progress of the overall OK-INBRE program, encourage
and assist faculty development and enhancement, identify resources and possible research collaborators as
needed, to evaluate progress of the individual RPI projects. The primary role of the SC will be to oversee the
development of the OK-INBRE network and provide advice to the PD/PI, including oversight of the scientific
progress of the network of investigators and the performance of each OK-INBRE component. Oversight and
evaluation of the OK-INBRE program will also be provided by the internal evaluator, Dr. Ann Chou, external
evaluation on a biannual basis, and the OK-INBRE Deans’ Council. The PI, Dr. Darrin Akins, and the Program
Coordinator, Dr. Mel Vaughan, will work as a team with all oversight committees to continually assess OK-INBRE
program outcomes. The Administrative Core also will provide research and career development activities for
faculty at the PUIs, CCs, and our TCCU partner institution. This Core will also provide coordination for the OK-
INBRE Summer Undergraduate Research Program, which aims to increase the number and quality of graduate
program and health care professional program applications submitted by students in Oklahoma. Career
development activities also will be coordinated by the Administrative Core, including sponsorship of (i)
Equipment Grants for infrastructure improvement, (ii) workshops, retreats and lectures (iii) enrichment courses
and career guidance symposia, and (iv) collaborative research opportunities for faculty to learn new techniques.
The Administrative Core also will provide reassignment time awards to PUI and CC faculty for development of
new courses that incorporate more experiential activities for students.